Development and Applications of Bioorthogonal Chemistry: Equipment Supplement

Development and Applications of Bioorthogonal Chemistry: Equipment Supplement
ABSTRACT
We have a long-standing interest in developing reactivity-based tools to address significant biological problems
that are difficult to solve using conventional techniques. In our MIRA application, we plan to continue our
studies of orthogonal chemical reactivity in the following three projects. In Project 1, we will design hydrazonyl
sultone (HS)-based fluorescence turn-on reagents for constructing FRET-based biosensors to probe class B
GPCR activation and signal dynamics in live cells. In Project 2, we will design β-lactam-encoded enzyme traps
for covalent capture and subsequent identification of protein lysine methyltransferase substrates in living cells.
In Project 3, we will develop covalent nanobody-based immunoPET radiotracers with enhanced performance.
The HS-mediated, binding-accelerated ligation reaction will be exploited to achieve greater PET imaging
sensitivity without undesired nephrotoxicity. We expect these studies will offer new capabilities of covalent
chemistry in biomedical research. This Equipment Supplement requests the acquisition of a Sartorius
OCTET-R2 Biolayer Interferometry (BLI) System. This equipment will enable us to rigorously characterize
covalent binding of protein substrates toward the designed enzyme traps described in Project 2, and optimize
the nanobody-based reaction partners for the HS-based immunoPET radiotracers described in Project 3.

Public health relevance
Development and Applications of Bioorthogonal Chemistry: Equipment Supplement Narrative This application seeks to combine the powers of genetic code expansion with bioorthogonal chemistry to develop new tools and capabilities for the studies of transmembrane receptor dynamics, intracellular enzyme functions, and antibody-based diagnostics in living systems. This Equipment Supplement requests the acquisition of a Sartorius OCTET-R2 Biolayer Interferometry (BLI) system, which enables us to rigorously characterize covalent binding of protein substrates toward the designed enzyme traps as well as optimize the nanobody- based reaction partners for the HS-based immunoPET radiotracers.